Biophysical Characterization of Subthalamic Local Field Potentials in Parkinson's Disease

PROJECT SUMMARY
Subthalamic deep brain stimulation (DBS) can significantly improve the motor symptoms and quality of life
of patients with Parkinson’s disease (PD). Recent advances in DBS technology are providing new
opportunities to interrogate and characterize the pathophysiology of PD using local field potential (LFP)
recordings. Previous LFP investigations brought to light the important role of beta-band (12-30 Hz) activity in
PD. However, we are still faced with a wide range of questions on the biophysics of subthalamic LFPs. For
example, How many subthalamic nucleus (STN) neurons need to be synchronized to generate a clinically
measurable LFP signal? What are the synaptic input characteristics responsible for that synchronization?
Where are those neurons located in the STN? The McIntyre lab has spent the last decade developing the
computational infrastructure to address these questions within the context of the human STN implanted with
clinical DBS electrodes. Therefore, we propose the integration of those advanced modeling tools with ongoing
human studies (directional STN LFP recordings – Dr. Walker, and chronic STN LFP recordings – Dr. Bronte-
Stewart) that are defining the clinical cutting edge of DBS LFP studies.
The goal of this Bioengineering Research Grant (PAR-19-158) is to apply the latest advances in patient-
specific LFP modeling to the analysis of directional STN recordings and chronic STN recordings in PD patients.
These analyses will allow us to address fundamental questions on the size and location of synchronous neural
populations in the STN, which have important implications for understanding the pathophysiology of PD. In
addition, our models will enable us to evaluate the variance in STN neural synchrony across populations of
patients, and over long periods of time within the same patient, both of which have important implications for
the engineering design of LFP-based DBS algorithms. The first step of this project will focus on evolving the
patient-specific LFP modeling infrastructure to accommodate directional DBS electrodes and adapt to different
electrode positions in each patient-specific STN volume. The second step of this project will use the patient-
specific LFP model system to identify the size and location of beta synchrony in 10 PD patients using
directional DBS recordings acquired during intra-operative experiments. Finally, we will quantify the
modulation of the size and location of the beta synchrony in 5 PD patients using chronic LFP recordings and
measurements taken at 4 different time points over a 1 year period.

Public health relevance
RELEVANCE Recordings of local field potentials (LFPs) from deep brain stimulation (DBS) electrodes have played an important role in expanding physiological understanding of Parkinson’s disease (PD). However, fundamental questions remain unaddressed on the underlying biophysics of LFP signals. The goal of this project is to create patient-specific computational models that enable dissection of the LFP signal at the cellular-level. These research tools will be customized to PD patients implanted with DBS systems.